Gulf Regional Area Stroke Program and Oklahoma

Project Summary
Our center for 40 years has been a leader in clinical trials testing new treatments for stroke and brain hemorrhage. In this application, we aim to continue serving as a leading regional coordinating center (RCC) in Stroke Net and have assembled a well- organized group of connected clinical sites linked by a history of productive collaboration and led by a multidisciplinary and ethnically diverse team. In Specific Aim 1, we intend to continue leading a RCC consisting of multidisciplinary teams to conduct clinical trials testing novel stroke therapies in acute stroke, stroke prevention, and stroke recovery. The UTHealth RCC will conduct clinical trials within a network of inter-connected sites throughout Texas and Oklahoma, involving both adult and pediatric patients with attention to the recruitment of minorities and women. In specific Aim 2, we will continue to provide expertise and leadership for the design of novel trials and propose trials testing new stroke therapies in acute stroke, stroke prevention, and stroke recovery. We will also provide translational expertise for the development of new stroke therapies from bench to bedside and for the development and testing of novel biomarkers. In specific Aim 3, we will expand our training career enhancement program for the trial workforce across our RCC partners. We will train clinician-scientists with high potential for independent research careers in stroke. We will also provide a career development and mentorship program for research study coordinators and program managers in our regional network.

Public health relevance
Project Narrative New treatments are urgently needed to treat, prevent, and promote recovery from stroke. We aim to continue to serve as a regional coordinating center in Stroke Net and conduct clinical trials in a regional network consisting of the hub at UTHealth in Houston and spoke stroke centers throughout Texas and Oklahoma. Our consortium provides stroke care to an incredibly diverse patient population in the South Central United States and has broad, multidisciplinary expertise in clinical trials for acute stroke, stroke prevention, and stroke recovery.